Training in Neural Control of organ Degeneration and Regeneration (NeuralCODR)

Neural activity directly controls the development and homeostasis of organ function. Yet, a surprising gap exists
between laboratories focused on vascular, gastrointestinal, immune, and musculoskeletal systems and those
focused on neurophysiology, neuromodulation, and neural injury. Traditionally, departments are organized by
organ system and this siloed structure leads to a physical and scientific jargon separation, impeding collaboration
and training. Hence, our understanding of how the central nervous system communicates with end organs
throughout the body is in its infancy. Neural Control of Organ Degeneration and Regeneration (NeuralCODR), a
cross-disciplinary training program unites 30 faculty members and 12 clinician researchers to form mentorship
teams within the largest medical research center in the world (Texas Medical Center). Mentorship teams include
a primary and secondary mentor (each from one of our three main areas of research: 1) neural development and
tools, 2) neural innervation and organ engineering, and 3) nervous system and peripheral organ disorders) and
a clinical mentor who provides much needed and rare exposure to real-world diseases, clinical challenges, and
human samples. NeuralCODR aims to: 1) catalyze the collision of talent and ideas that spawn research projects
bridging neuroscience with organ systems through facilitated interactions, 2) build co-mentor teams that include
neuroscience, organ systems, and clinical perspectives, ensuring trainees are guided toward a unique research
niche, and 3) train fellows in research rigor, analysis, and career skills that support their development as scientific
leaders. NeuralCODR leverages a network of faculty who collaborate on projects that bridge the gap between
organ system biology and engineering and neural function, degeneration and regeneration, as evidenced by an
impressive list of multi-laboratory shared grants, publications, and nascent collaborations. The training structure
emphasizes experiences in organ engineering and organ physiology laboratories in parallel with education in
neurophysiology and neural engineering, translational theory, and practice. Currently, two NeuralCODR Houston
Methodist-specific postdoctoral positions exist, thanks to a philanthropic endowment that has allowed us to build
the program structure and to test both the coursework and mentorship team concept. Trainees are funded for
two years, during which time they have access to a core curriculum, career development and program
enrichment opportunities, symposiums/retreats, and elective courses. Year one culminates with the submission
of an NRSA and a manuscript based on trainees’ development of a transformative research project that
incorporates non-neuroscience expertise and tools into a neuroscience problem. Year two solidifies the
relationships between the mentorship team and trainee and provides training in laboratory management, didactic
teaching, and mentorship skills. T32 funding will allow us to increase the current model to six postdoctoral training
slots. This training program will foster a new generation of scientific leaders who pioneer research on the
connected pathways between brain and organ systems to solve fundamental challenges in neuroscience.

Public health relevance
PROJECT NARRATIVE We propose a cross-disciplinary training program that brings together regeneration biologists, neurophysiologists, and clinician researchers to form mentorship teams within the largest medical research center in the world: The Texas Medical Center. This training program will foster a new generation of scientists who will in turn help build a new frontier of biology: neural control of organ degeneration and regeneration.